Understanding Sarcoidosis Susceptibility and Disease Burden Through Multi Omics

ABSTRACT
Sarcoidosis is a systemic granulomatous disease with striking heterogeneity of clinical course and increasing
mortality and morbidity rates. Diagnosis is difficult and predicting disease outcomes is virtually impossible. While
it is known that sarcoidosis likely involves host genetic susceptibility and a dysregulated immune response to
any number of environmental factors, the mechanisms by which granulomas form and the determinants of
severity and disease manifestations remain elusive. Our team has been at the forefront of genetics and
transcriptomics in sarcoidosis, including the identification of genes for susceptibility, severity, ancestry- and
organ-specific effects, the first and only single-cell RNA sequencing study of sarcoidosis and the first GWAS of
pulmonary fibrosis in patients of African ancestry (AA). These findings provide the foundation for further
dissection of cellular mechanisms that lead to systemic immune dysregulation and tissue-specific inflammatory
response. Our current proposal will advance the field by filling critical gaps in sarcoidosis research,
including the lack of mechanism and biomarkers for sarcoidosis and its patient-specific disease burden,
poor consensus of existing genetic and genomic studies, and the absence of mechanistic connections
between immune profiles in the periphery and affected organs. We will exploit the clinical, immunological,
genomic, and bioinformatic expertise of our team to apply an innovative, and integrative multi-omic approach to
fil these gaps. Specifically, in Aim 1, we will use high-througput plasma proteomics from over 1000 sarcoidosis
patients of AA and European ancestry (EA), 800 healthy and 275 diseased controls to a) distinguish sarcoidosis
patients from healthy and other immune-mediated disease controls, b) to distinguish patients with high disease
burden from those with low disease burden, and c) elucidate ancestry and disease course specific mechanisms
and biomarkers. In Aim 2, we will identify candidate genes for susceptibility to and disease burden of sarcoidosis
by a) Conducting a large TWAS of over 2,000 EA and AA patients compared to 3900 healthy controls, and b)
replication and characterization of these effects via scRNAseq of an independent cohort, and c) prioritize
transcriptomic effects via colocalization of genetic and QTL effects. Finally, in Aim 3, we will a) identify candidate
genes that are differentially expressed in granulomas via spatial transcriptomics and whose protein products are
dysregulated in bronchoalveolar lavage (BAL) and b) identify genes best suited for functional and drug target
studies based on integrating the data collected across multiple biological systems and data types. The success
of our work will be facilitated by the extensive genetic, genomic, and clinical data available to us from our own
cohorts and the TOPMed Consortium (of which we are members) and its rigor supported by strong preliminary
data indicative of novel therapies for AA and high disease burden patients.

Public health relevance
NARRATIVE Sarcoidosis is an enigmatic disease that varies from mild to life-threatening, is difficult to diagnose and even more difficult to predict. Our project aims to identify the immune factors that can help us understand disease mechanism and accurately characterize patients, particularly women, people of African ancestry, and those most likely to be severely affected. This project will capitalize on our unique combination of unmatched data, cutting-edge technologies, and dedicated researchers to lay the groundwork for diagnostic, prognostic, and treatment advances.